PhysioNet: A FAIR and sustainable data repository

Freely accessible, curated, and annotated clinical and physiological data – and tools to manage and analyze
them – are foundational to fully harnessing the promise that machine learning/artiﬁcial intelligence (ML/AI)
and signal and image processing hold for advancing and personalizing healthcare. Since 1999, PhysioNet has
pioneered the free access to large, high-impact, de-identiﬁed physiological and clinical databases and
associated analysis tools. PhysioNet is a recommended data repository for numerous publishers and the NIH,
and its current content of over 350 diverse databases, software packages, and ML/AI models is used
extensively across the world. In the past decade, the PhysioNet user community has grown dramatically: In
2023 alone, ~30,000 new users registered for accounts, nearly 7,000 publications referenced PhysioNet and its
contents, and over 80 new databases or software packages were published on the platform. With such rapid
growth, PhysioNet faces signiﬁcant challenges in meeting the evolving needs of the community and in
managing the growing number of new submissions. Balancing these demands while upholding a rigorous
editorial review process is essential to ensure that published projects maintain the high standards of quality
expected by the research community. To be able to review, curate, and publish the growing number of
contributions submitted to PhysioNet in a timely manner, and to meet the dramatically increasing demand for
high-quality databases and analysis tools, the PhysioNet team must adapt its operations. With funding through
this U24 mechanism, the team proposes to 1) Streamline access to high-quality content by decreasing the time
from contribution through curation to publication, enabling more eﬃcient data discovery, and reducing the
time for users to gain access to data resources; 2) Develop pathways for long-term access and sustainability by
consolidating PhysioNet with MIT infrastructure and developing models for institutional memberships; and 3)
Foster an inclusive and dynamic community that encourages active participation and collaboration among
users, researchers, and developers by strengthening community engagement, by developing methods for
impact assessment, and by aligning resources and resource development with user needs. Attaining these aims
will put PhysioNet on a sustained path of growth, enabling it to keep pace with the exponentially increasing
demand for its resources.

Public health relevance
Since 1999, PhysioNet has been a leader in providing free access to large, impacƞul databases of de-idenƟﬁed physiological and clinical data. These resources are essenƟal for advancing machine learning and arƟﬁcial intelligence (ML/AI) in healthcare. Over the past decade, the use of PhysioNet data has grown near exponenƟally, creaƟng a need to streamline and automate its operaƟons to conƟnue to serve its global user community with high-quality, carefully curated data.